Astrocyte-Neuron Network Activity During In Vivo Brain Stimulation

PROJECT SUMMARY
Intracortical microstimulation (ICMS) is a primary component of fundamental neuroscience research and holds
great potential for sensory restoration or sensory feedback in neuroprosthetics. Despite the wide use of electrical
stimulation in neuroprosthetics and interventions such as spinal cord stimulation and deep brain stimulation
(DBS), the fundamental physiological and mechanistic properties defining therapeutic efficacy remain poorly
understood. For example, it is still unclear which cell types are activated, what role they play in therapeutic
outcomes, and how to tune stimulation parameters to selectively elicit relevant activity in those cell types for
sensory restoration. Of particular interest is the contribution of non-neuronal cells such as astrocytes. Astrocytes
are emerging as important cells in the modulation of neuronal activity during sensory processing in which they
respond to neurotransmitters with calcium elevations leading to the release of neuroactive substances to regulate
synaptic function (i.e., gliotransmission). Importantly, the time scale in which astrocytes modulate neuronal and
synaptic activity is consistent with ICMS-induced neural activity. It is because of these recently appreciated roles
regarding astrocyte-neuron communication that astrocytes have been suggested as a vital component to brain
stimulation. However, it is unclear how astrocytes respond to clinically relevant stimulation parameters on a
network level and how that activation subsequently modulates neuronal activity in an awake animal. To address
this gap in knowledge, this proposal will first quantify the calcium activity in cortical astrocytes and across a larger
network induced by ICMS with different frequencies and temporal patterns known to have differential therapeutic
efficacy using both two-photon microscopy and mesoscale imaging. Next, this proposal will quantify how ICMS-
induced neuronal activity is modulated when astrocyte calcium activity is selectively increased (optogenetics) or
decreased (viral transduction of a plasma membrane calcium pump) to determine how astrocytes regulate
neuronal network activity during ICMS. Because astrocyte calcium activity regulates how these important cells
modulate neuronal activity, the cumulative results of this proposal will provide valuable insight for fundamental
neuroscience research and the design of stimulation paradigms to elicit astrocyte activity relevant to sensory
restoration.

Public health relevance
PROJECT NARRATIVE Intracortical microstimulation (ICMS) is a versatile tool to study the fundamental physiology of the nervous system and restore sensation in neuroprosthetics; however, the basic neurobiological mechanisms, with relation to which cell types are activated, in what spatiotemporal activation, and how they contribute to therapeutic efficacy remain poorly understood. There has been an increased appreciation of astrocytes' contribution to regulating proper coordination of neural activity during sensory processing, but it still remains unclear how astrocytes respond to ICMS on a network level and how their activation modulates neuronal activity. Using a combination of two-photon microscopy, mesoscale imaging, and optogenetics or genetic manipulation of astrocyte calcium activity, this proposal aims to determine the dynamic relationship between astrocyte and neuronal calcium activity during ICMS and understand how astrocytes respond to and may contribute to the therapeutic efficacy of ICMS paradigms.